PELVIC FLOOR CHANGES BEFORE AND AFTER BIRTH

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The goals of this study are: 1. To identify the rate of occurence of bowel and bladder incontinence, sexual dysfunction, body changes, and perineal pain [pre and postpartum], in healthy childbearing women without genital tract trauma at birth. 2. To compare pelvic floor changes in women with and without genital tract trauma. 3. To determine the effect of pelvic floor changes on maternal quality of life.